A mouse model with humanized telomere homeostasis

Abstract The goal of this project is to develop a mouse model that acquires human-like telomere homeostasis for the study of human aging, cancer, and other age-related diseases. In humans, most somatic cells lack telomerase expression and cannot replenish their telomeres. Consequently, telomeres progressively shortened upon successive cell divisions and function as an aging clock. Accordingly, telomere shortening is a critical factor of human aging and telomerase activation is essential for the development of most human cancers. On the other hand, some other organisms, including laboratory mice, do not exhibit telomere-mediated replicative aging. Mice possess long telomeres and ubiquitous telomerase activity in adult tissues. This interspecies difference has become a bottleneck for addressing many fundamental questions in human aging and cancer biology using mouse models. To tackle this challenge, we have started to create a mouse strain with humanized telomere homeostasis. Here, we have engineered a humanized mouse Tert allele (hmTert) by using regulatory sequences from the human TERT gene (hTERT) to replace their mouse counterparts. We found that the hmTert gene regulation recapitulated that of the hTERT gene during mouse development and in mouse adult tissues. In this application, we propose the following three specific aims: 1) Create a mouse strain with hmTert alleles and human-like short telomeres; 2) Study replicative aging in mice with humanized telomere homeostasis; and 3) Determine lifespan and health-span of mice with humanized telomere homeostasis.

Public health relevance
Project Narrative Mice have much longer telomeres than humans. While telomere shortening is a key mechanism of human aging, laboratory mice do not exhibit telomere-mediated aging. In this application, we plan to develop a genetically engineered mouse strain with humanized telomere homeostasis. Such mice should become an improved model for studying human aging and cancer.